Inclusion and participation of older adults from underrepresented populations in cognitive aging and Alzheimer's disease-related research

PROJECT SUMMARY/ABSTRACT (parent award)
Alzheimer’s disease (AD) is a major public health burden and disproportionately affects underrepresented
populations (URPs), including underrepresented ethnoracial groups and those with low socioeconomic status.
URPs are chronically underrepresented in AD clinical research, which has substantial scientific and ethical
ramifications. The separate and interacting contributions of sociodemographic and other factors to multiple
levels of research participation, including enrollment, retention, and study task completion, are not well
understood. Based on current health disparities theoretical frameworks, like the biopsychosociocultural model,
multiple factors need to be considered. Therefore, the overall scientific objective of this proposal is to
investigate multiple biopsychosocial factors affecting inclusion and participation of URPs in different research
settings with a specific focus on ethnoracial and low educational attainment URPs. An innovative approach will
be used to examine these important hypotheses by leveraging three existing cohorts from different research
settings: (1) the Brain Health Registry (BHR), a cognitive aging-related longitudinal research registry,
N>70,000, (2) the Alzheimer’s Disease Initiative (ADNI), an in-clinic observational AD study, N>2,000, and (3)
the Health and Retirement Study (HRS), a population-based aging study, N>20,000. The two main hypotheses
are (1) Associations between URP status and research participation are affected by multiple
biopsychosociocultural factors. We will examine the moderating role of biopsychosociocultural factors on URP
research participation in BHR and ADNI; (2) Eligibility criteria of AD trials contribute to underrepresentation of
URPs. We will apply a list of current AD trial eligibility criteria to the population-based HRS sample to
determine and statistically compare sociodemographic characteristics of eligible/ineligible participants. We will
further explore the contributions of trial design characteristics on eligibility. This project is both highly novel and
significant as it will be the first to conduct an in-depth examination of multiple biopsychosociocultural factors
affecting URP inclusion and participation in a variety of different settings. Improved understanding of the role of
biosychosociocultural factors on URP research participation is critical to elucidate sources of research
participation disparities frequently affecting URPs. Thus, results are likely to have important public health
implications, as this study may inform targeted research inclusion and engagement strategies to improve
diversity. This research plan is complemented by a training plan that builds on the candidate’s recent transition
from clinical research psychology to the aging and AD field, and therefore includes training in (1) cognitive
aging/AD and related clinical trials; (2) complex data sets analysis, advanced biostatistics; (3) AD disparities;
(4) URP research participation disparities; (5) professional development. The combined research and training
plans will prepare the candidate for a successful independent research career focused on increasing diversity
in cognitive aging and AD research.

Public health relevance
PROJECT NARRATIVE (parent award) A major barrier to the development of new Alzheimer’s disease (AD) treatments, is that many clinical studies recruit slowly and/or never reach their target enrollment and this problem is further exacerbated by a lack of representativeness of research volunteers in terms of race, ethnicity, sex, education, and socioeconomic status. Improving the inclusion and participation of underrepresented populations (URPs) in research is critical to increase the applicability, accuracy and generalizability of AD study results to diverse populations. Therefore, this proposed research project has the specific goal of providing increased understanding of biopsychosociocultural factors which affect inclusion and participation of URPs in AD research with the long- term goal of informing strategies to improve diversity and generalizability of AD research.